The role of orosomucoid1 in skeletal muscle aging during an optimized autophagy activity intervention

Project Summary/Abstract
The age-related loss of muscle mass and function (e.g., strength and physical performance) is known as
sarcopenia. It is a muscle disorder that leads to increased physical fatigue, falls, and fractures and is highly
associated with hospitalization and mortality. Despite its remarkable clinical relevance, no pharmacological
agents are approved for this condition, and exercise training remains the only recommended therapy.
Nevertheless, some pharmacological agents alleviate sarcopenia in mice and humans when prescribed as a
single-mode therapy, but combining them with exercise has produced frustrating outcomes. Given the pressing
need to identify a viable drug that enhances exercise benefits, we postulated that enhancing autophagy by
administering Tat-Beclin1 would boost exercise adaptation in old mice. Our focus on autophagy is due to its
requirement to preserve muscle health. Our preliminary data shows that combining Tat-Beclin1 and exercise
increases autophagy status, grip strength, and endurance capacity. To determine the molecular mechanisms
by which adding Tat-Beclin1 to an exercise regimen elicits functional benefits in aged muscles, we performed a
proteomic analysis in the gastrocnemius (GAST) muscles. Our data revealed orosomucoid1 as one of the top
proteins upregulated in the GAST muscles of old mice subjected to integrative therapy. Orosomucoid1 is an
acute-phase protein shown to attenuate physical fatigue and increase endurance capacity and glycogen
content in the muscles of young mice. The central hypothesis is that orosomucoid1 attenuates sarcopenia and
is necessary for the improvements induced by combining Tat-Beclin1 and exercise. The hypothesis will be
tested with two specific aims. Aim 1 asks whether orosomucoid1 is necessary for the improvements induced by
Tat-Beclin1 and endurance exercise. We will electroporate a miRNA encoding orosomucoid1 in the hindlimb
muscles of male (26 months old) and female (28 months old) mice and subject animals to exercise, Tat-
Beclin1, or a combination of the two therapies for two months. A miRNA control encoding a nontargeting pre-
miR hairpin sequence in the contralateral leg to serve as an experimental control. In vivo muscle function and
comprehensive ex vivo assay will be performed. Aim 2 asks whether increasing orosomucoid1 levels can
prevent, halt, or revert sarcopenia. We will administer exogenous purified orosomucoid1 (IP) for 30 days in 18-,
26-, and 30-month-old male and 18-, 28-, and 32-month-old female mice. Functional, biochemical,
morphological, and molecular (i.e., proteomics) will be assessed. The proposal is significant because it
addresses a relevant and poorly understood area of muscle biology, and it could put into development a new
therapeutic approach to tackle sarcopenia.

Public health relevance
Project Narrative The lack of an effective therapy for aging-associated loss of muscle mass and function (Sarcopenia) is due to our poor understanding of crucial biological mechanisms that induce it. This proposal centers on investigating how combining a drug with endurance exercise elicits superior benefits in the muscle function of aged mice.